Neurocognitive Foundations of Morphological Processing in Children with Dyslexia

Project Summary
Developmental dyslexia is a specific learning disability characterized by word reading difficulties that impacts 5-
12% of children in the US. Dyslexia is most commonly associated with impaired sensitivity to language sounds
(phonological awareness). However the ultimate goal of reading is not to access sound, but to access meaning.
Although the neurocognitive mechanisms underlying sound processing and its impairments in dyslexia are
relatively well understood, little is known about the role and neurocognitive basis of sensitivity to units of
meaning (morphological awareness) in dyslexia. This is a major gap in knowledge, as children with dyslexia
typically demonstrate poor morphological awareness, and decoding polymorphemic words becomes increasingly
important for academic success through elementary and middle school. Guided by the Lexical Quality framework
and Connectionist theories of reading, the current proposal will investigate the neurocognitive mechanisms
underlying morphological processing in relation to word reading children with dyslexia (4th-5th grade) as well as
age-matched (4th-5th grade) and skill-matched (2nd-3rd grade) typical readers. I will collect structural and functional
magnetic resonance imaging (MRI) data during a novel morphological processing task. Participants will also
complete a comprehensive assessment of oral language, reading, and cognitive skills. First I will characterize
the neurocognitive basis of morphological processing and its development in typical readers. I will then test the
hypothesis that the neurocognitive basis of morphological processing differs between typically developing
children and those with dyslexia. Finally, I will identify the neural correlates of morphological processing that are
associated with behavioral measures of word reading (dis)ability, advancing our understanding of dyslexia by
connecting brain to behavior. This work is of theoretical and practical importance, as morphology becomes
increasingly important for successful reading over time, yet neurocognitive models of reading and dyslexia rarely
include morphological processes. Additionally, morphology may be one powerful way to compensate for
phonological deficits in dyslexia. Findings may inform educational and clinical practices to capitalize on
morphological processing as a promising compensatory mechanism, and provide research-based intervention
for struggling readers. The proposed study will provide ample opportunities to complete the fellowship training
goals by advancing the trainee’s: 1) conceptual knowledge of dyslexia, 2) technical training in fMRI
neuroimaging, 3) advanced methodological knowledge, and 4) translational skills in working with educators and
clinicians. This work will be conducted at MIT and MGH IHP, both vibrant academic communities with extensive
resources for pediatric neuroimaging, and supervised by leading experts in the field with decades of experience
conducting research related to reading and dyslexia.

Public health relevance
Project Narrative Developmental dyslexia is a deficit in accurate or fluent word reading typically associated with deficits in sound processing affecting 5-12% of all school-aged children. Neuroimaging research into sound processing in dyslexia has greatly informed our understanding of dyslexia and its treatment; however, much less is known about how individuals with dyslexia process units of meaning. Using a combination of neuroimaging and behavioral methods, the proposed project will investigate morphological processing in a sample of child readers with and without dyslexia, potentially informing both literacy theory and research-based educational practices for struggling readers.